DATA COLLECTION SERVICES FROM THE NORTH CAROLINA CENTRAL CANCER REGISTRY

PROCUREMENT OF DATA COLLECTION SERVICES FROM THE NORTH CAROLINA CENTRAL CANCER REGISTRY IN SUPPORT OF THE PILOT OF PATTERNS OF CARE STUDIES FOR THE NCI